Effective CMV-based SIV vaccine regimens for newborn infants via IL-10 modulation

The goal of this grant is to develop CMV-vectored SIV and eventually HIV vaccines that are effective in
newborn infants. First-generation RhCMV-vectored SIV vaccines (RhCMV/SIV) are effective in adult animals
previously infected with wild-type RhCMV but do not protect newborn animals. Possible explanations for this
failure include (i) dramatically different function of the developing immune system of newborns and (ii) absence
of wild-type RhCMV and its transformative effects on immunity (>98% of newborn babies are CMV uninfected).
We demonstrated that a second-generation vaccine lacking the viral IL-10 gene (RhCMVdIL10/SIVgag) does
protect RhCMV-seronegative older infants (8-10 months). Protection via RhCMVdIL10/SIVgag is associated
with impressive transcriptomic changes similar to those reported for adult animals receiving RhCMV/SIV. Viral
IL-10 function is therefore an impediment to RhCMV/SIV efficacy, particularly in younger animals that may
have relatively greater function of tolerogenic, anti-inflammatory pathways.
Given our favorable results in older infants, it is likely that RhCMVdIL10/SIVgag is capable of priming similar
responses in newborns. To counter the possibility that newborn recipients may mount quantitatively lower T-
cell responses, we additionally developed an Ad26 vector that delivers SIVgag together with dominant-
negative IL-10 receptor. Delivery of antigen with dominant-negative receptor ensures that the relevant APCs,
i.e., those presenting antigen, are unaffected by ambient IL-10. This unique vaccine will be used as a boost.
We hypothesize that restrained IL-10 signaling in newborns vaccinated with RhCMVdIL10/SIV permits
development of high-frequency, fully functional T cells that are protective against SIV. If the hypothesis is
correct then this work will dramatically advance research into vaccination of newborns against HIV and other
diseases, simultaneously providing measures of the needed responses and new tools to stimulate them.
Aim 1: Test protective efficacy of viral IL-10-deficient RhCMV/SIV vaccines in newborn animals while
comprehensively profiling innate immune subsets. Our hypothesis predicts that the viral IL-10-deficient
vaccine, RhCMVdIL10/SIVgag, stimulates improved T-cell responses and significant protection in newborn
animals; furthermore, protection is associated with transcriptional changes concentrated in innate cells and
associated with improved T-cell function.
Aim 2: Determine if newborn immune responses to RhCMV/SIV can be boosted by Ad26-vectored
vaccines delivering vaccine antigen with or without dominant-negative IL-10 receptor. Adenovectors
stimulate strong responses acutely and have been shown to boost protective responses to CMV-vectored
vaccines. Here we test an Ad26-based booster vaccine that additionally inhibits IL-10 signaling in APCs to
evade regulatory responses that are particularly strong in newborns.

Public health relevance
We are seeking an effective vaccine against the human immunodeficiency virus (HIV), which has killed about 35 million people. The most effective current vaccine candidate is carried by another virus, cytomegalovirus (CMV), and is effective in some adults but not newborn infants. In this work we will test if combination of the CMV candidate vaccine with an adenovirus-based vaccine, together with new strategies for inhibition of the immunosuppressive IL-10 protein, can protect newborn infants.